Tenth Cooley's Anemia Symposium: Basic Science, Clinical Research, and Patient Healthcare for Thalassemia Syndromes.

? DESCRIPTION (provided by applicant): Tenth Cooley's Anemia Symposium - Thalassemia syndromes affect at least two million people worldwide, and researchers believe that several hundred million people may be silent carriers of a thalassemia trait, making it one of the most common single-gene disorders in humans. The Tenth Cooley's Anemia Symposium, to be held at Loews Chicago O'Hare Hotel October 18-22, 2015, represents the largest global gathering of thalassemia experts, and provides one of the few instances each decade that the international research community, the pharmaceutical industry, and funding agencies dedicated to fighting this blood disorder come together. This 3.5-day conference will convene approximately 350 attendees, including scientific researchers working in the fields of molecular and cellular biology stem cell biology, and genetics, as well as clinical specialists in hematology, hematology, nephrology, pathology, radiology, stem cell transplantation, transfusion medicine, and pediatrics, among other fields. The main objectives of this conference are to: (i) Provide a neutral forum for discussion of existing clinical data, emerging strategies, and future directions for research and treatment of genetic hemoglobinopathies, including Cooley's anemia; (ii) Attract/showcase early career and underrepresented investigators (including women, ethnic/racial minorities, and persons with disabilities) via short talks, posters, travel fellowshis, and to provide opportunities to interact with senior investigators; (iii) Disseminate the conferenc proceedings to the international community; and (iv) Foster collaboration between academia, medicine, industry, and government to promote knowledge exchange and successful translation of research into improved diagnostics and patient therapies for thalassemia and treatment- related organ damage. Cutting-edge topics to be discussed during this symposium include globin gene regulation, iron metabolism and hepcidin, management of thalassemia symptoms and iron overload, and preliminary results of clinical trials using gene therapy, stem cell transplantation, and novel drug pathways. The goals of this Symposium strongly support the mission of the National Heart, Lung, and Blood Institute (NHLBI) and National Institute of Diabetes and Digestive and Kidney Diseases (NIDDK) in that the conference will focus on multiple priority areas of need: to advance hematology research and treatment of disorders of hemoglobin, and to improve safety and efficacy in blood transfusion medicine - including the diagnosis, management, and prevention of iron overload and subsequent damage to the kidney, liver, lungs, heart, and endocrine system. Discussions originating from the conference, and their dissemination via publication in a volume of Annals of the New York Academy of Sciences, will have global impact by improving scientific understanding, advancing breakthrough therapies, and ultimately reducing the healthcare burden of this family of genetic blood disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: Tenth Cooley's Anemia Symposium - Thalassemia syndromes are a group of genetic blood disorders that affect hemoglobin, the protein within red blood cells that carries oxygen from the lungs to the rest of the body and removes carbon dioxide waste. Inherited mutations to these genes can cause chronic anemia, bony deformities, reduction in pediatric growth, and other complications. Children inheriting faulty globin genes from both parents, such as in thalassemia major/Cooley's anemia, have severe anemia requiring monthly blood transfusions. While transfusions reduce the symptoms of thalassemia, over time, almost every patient experiences transfusion- induced iron overload and life-threatening organ damage to the liver, kidney, heart, and lungs, among others. Thus, thalassemia syndromes represent a significant burden to healthcare resources in the United States and globally, as patients require extensive medical care throughout their lives. The Tenth Cooley's Anemia Symposium, which will be held at Loews Chicago O'Hare Hotel on October 18 - 22, 2015, is the preeminent forum for convening scientists, clinicians, industry, caregivers, policy makers, and patient support groups, on research and treatment for thalassemia syndromes. Since the first joint symposium of the New York Academy of Sciences and the Cooley's Anemia Foundation in 1964, breakthrough research and early results of clinical trials shared at this conference (held every 5 - 6 years) quickly become integrated by scientific researchers and healthcare providers alike; thus expediting translation of new discoveries into possible medical treatments, and successful clinical trials into approved therapies. The 2015 conference will bring together approximately 350 participants from around the world to discuss basics science research and emerging therapies using cutting-edge tools and treatments, including stem cell transplantation and gene therapy, which may have the potential to cure thalassemia. Publication of the conference proceedings in Annals of the New York Academy of Sciences will disseminate the information exchanged at the meeting to the global research and healthcare communities.